Continuation of Risk, Insurance, and the Family

This project is concerned with the health, productivity, and well being of families in developing countries. Households are exposed to various risks: illness and disability, erratic rainfall, crop disease, macro crises, and fluctuating prices in primary goods. Such shocks cause stress for both children and adults and can have long-term deleterious consequences. Ex post coping strategies and ex ante actions may be onerous and do not always suffice. This research is concerned with "insurance" against shocks and seeks to understand and quantify vulnerability, and to compare and contrast the roles of kinship networks, government policy, and more formal financial institutions. The roles of the informal and formal sectors many vary over space even within a country (e.g., the semi-arid Northeast of Thailand versus communities in industrialized areas near Bangkok), and vary over time (e.g., periods of growth vs. the years'financial crisis or, as now, resumed growth). Households living in an economy like Thailand with high sustained GDP growth may be more likely to have accumulated wealth and other buffers, at least if the benefits of economy-wide growth have trickled down. Thus the ability of households to make transitions to higher-income occupations (e.g., non-farm businesses versus subsistence agriculture), and gain access to the formal financial system is likely a key part of long-term poverty reduction and risk amelioration. Among the more narrow specific aims of the research: to understand local, regional, and national economies as integrated systems and to study the dynamics of growth, inequality, and poverty via models of individual and household selection into new occupations, and financial access, subject to imperfect credit markets and other constraints;to formally model the impediments to exchange which give families, networks, and clusters of "collective groups" a role, even in the context of larger local and economy-wide markets;to conduct statistical and econometric analyses: data-tabulations, statistical comparisons, fits to each of the various theoretical/econometric models, and formal comparisons across the various models including non- nested alternatives associated with impediments to exchange;to understand and quantify the obstacles: private information (adverse selection, moral hazard, hidden states), limited communication, incomplete contracts, reneging (limited committed, punishment), and transactions costs;to evaluate the impact of actual and potential government policies (financial liberalization, "one million baht" village funds, 30 baht health care);to continue field research with the annual panel and monthly micro panel;to establish an innovative web-based research data base archive with CIS functionality with all existing Thai national data;and to enhance infrastructure to further facilitate international research into these and related issues.